THIN INSULATING COATINGS FOR IMPLANT DEVICES

This research will develop thin insulating coatings for implant devices that are essentially impermeable to water and tissue fluids. Thin insulating coatings will be fabricated by a low-temperature sputtering process. High quality coatings will be formed into a specially engineered multi layer structure designed to enhance interfacial bonding and eliminate pin-holes. The resultant insulating coatings may be used as an outer protective barrier for neural prosthetic implants, such as neural microprobes, and their connecting fixtures.